Phospholipid-Mediated Metabolic Control in the Pathogenesis of NAFLD

PROJECT SUMMARY/ABSTRACT
Altered regulation of lipid and glucose homeostasis, most often in the setting of insulin resistance and obesity,
is central to the pathogenesis of non-alcoholic fatty liver disease (NAFLD). Because current management
options remain limited, the discovery of new metabolic pathways will serve to identify novel opportunities for
pharmacologic intervention. This research proposal addresses the unanswered question of whether membrane
phospholipids regulate nutrient homeostasis. Our long-term goal is to understand how phospholipid-mediated
metabolic control can be leveraged for therapeutic purposes. The objective of this research is to determine the
molecular mechanisms whereby sensing of membrane phosphatidylcholines by phosphatidylcholine transfer
protein (PC-TP) is translated into metabolic control by thioesterase superfamily member 2 (Them2), a
mitochondria-associated long chain acyl-CoA thioesterase. The central hypothesis is that key regulatory events
occur in the skeletal muscle when PC-TP binds specific membrane phosphatidylcholine molecular species and
then activates Them2. The rationale is that regulation of skeletal muscle metabolism by Them2 should yield
new insights into hepatic insulin resistance and steatosis. Guided by extensive preliminary data, the central
hypothesis will be tested in three specific aims: 1) To demonstrate that Them2 controls lipid and glucose
metabolism in skeletal muscle; 2) To define mechanisms whereby Them2 in skeletal muscle promotes hepatic
steatosis; and 3) To elucidate the molecular determinants of Them2 activity and regulation by PC-TP. In Aim 1,
mouse models will be used to determine mechanisms whereby Them2 regulates fatty acid and glucose
metabolism in skeletal muscle and promotes insulin resistance in response to overnutrition. Cell autonomous
functions of Them2 will be gleaned from systematic studies in cultured myotubes. Aim 2 will establish the
mechanisms in high fat fed mice whereby Them2 in skeletal muscle promotes hepatic insulin resistance and
steatosis. Cultured hepatocytes will be used to determine whether Them2-dependent myokines or extracellular
vesicles released from myotubes control hepatic lipid and glucose metabolism. Aim 3 will determine structural
characteristics that enable Them2 to respond to changes in membrane phosphatidylcholine composition. Small
molecules designed to bind and inhibit Them2 will be used as probes to characterize Them2 function and
interactions with PC-TP using an array of biophysical techniques. Phosphatidylcholine-dependent
conformational changes in PC-TP will be leveraged to identify specific motifs that are critical for Them2 activity
and stability. The interacting domains of Them2 and PC-TP will be identified and confirmed by mutational
analyses. Overall, this proposal will elucidate new mechanisms of phospholipid-mediated metabolic regulation
that control hepatic nutrient metabolism, which is significant because the fatty acyl composition of membrane
phosphatidylcholines varies in health and disease. These studies are expected to establish Them2 as a
tractable target for the management of NAFLD.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the discovery of a phospholipid-dependent pathway that controls lipid and glucose homeostasis is expected to provide new insights into the pathogenesis of insulin resistance and its complications, including non-alcoholic fatty liver disease (NAFLD). The proposed studies are relevant to the mission of the NIDDK because they are expected to identify new therapeutic targets for the management of NAFLD.